BK channels in Cardiac physiology

Mitochondria have been shown to play a central role in cardiac contractility and the process is tightly regulated
by electron transport chain (ETC) efficiency. Mitochondrial functions including ATP generation and ROS
production by ETC are tightly coupled with ionic homeostasis and coordinated regulated signaling between
nuclear-cytoplasmic and mitochondrial components. Tremendous progress has been made in deciphering the
mechanistic role of mitochondria in protecting the heart from cardiac hypertrophy in animal models. Yet, it
remains a substantial challenge to dissect the critical contribution of mitochondria to cardiac hypertrophy and to
establish a rigorous relationship between energetics, signaling pathways, and specific aspects of cellular and
organ hypertrophy. The potassium channel sensitive to voltage and calcium (BK) present in cardiomyocytes has
been shown as a splice variant of plasma membrane BK and is exclusively present in mitochondrial membranes
(referred to as mitoBK). Though activation of cardiac mitoBK is known to play a role in cardioprotection possibly
by regulation of mitochondrial function, the precise mechanism of mitoBK in regulating cardiac function and
protecting the heart from pathological hypertrophy (or cardioprotection from IR injury) is not yet established. We
will now test the hypotheses that: cardiac mitoBK protects against pathological cardiac hypertrophy by regulating
mitochondrial biogenesis and function via modulating the levels of UCPs, through signaling pathways governed
by PGC-1α, and FOXO3a. Our published, as well as preliminary data, show that: 1) mitoBKCa is encoded by
Kcnma1 gene, and a DEC splice variant governs its mitochondrial localization; 2) absence of mitoBK causes
cardiac hypertrophy, fibrosis, and cardiac dysfunction; 3) absence of mitoBK augment cardiac hypertrophy after
pressure overload insult whereas genetic activation protects the heart, 4) expression of mitoBK is vital for
handing mitochondrial calcium and ROS levels after pressure overload, 5) absence of mitoBK results in changes
in expression of UCPs, PGC-1α, and FOXO3a. Our preliminary data support our hypothesis that cardiac mitoBK,
exclusively present in the mitochondria of adult cardiomyocytes, plays a cardioprotective role in cardiac
hypertrophy. This will be tested by an array of multidisciplinary collaborative approaches using mouse genetics.
In that regard, we will pursue the following specific aims: 1) To determine the role and mechanisms of mitoBK
channel mediated changes in mitochondrial function in left ventricular hypertrophy; and 2) To elucidate
mechanisms whereby retrograde signaling influences mitoBK activity, and expression of transcriptional
coactivators and UCPs in left ventricular hypertrophy. This research program will be the first proposal that
will determine the precise signaling mechanism of how cardiac mitoBK channels directly play a role in
mitochondrial physiology, and cardiac function, and protect the heart from pathological cardiac hypertrophy.

Public health relevance
RELEVANCE. Cardiac potassium channels localized to mitochondria are implicated in its volume regulation and protecting the heart from lack of oxygen like that occurring during heart infarct. Here, we propose to define its novel role in cardiac hypertrophy and the regulatory mechanism involved. The results of this investigation will allow the advancement of heart failure medicine and provide new molecular targets for therapeutics.